Core C - Communication and Dissemination Core

COMMUNICATION AND DISSEMINATION CORE: Revised Project Summary/Abstract
The Communication and Dissemination Core promotes the activities and achievements of the Life Course Center (LCC). The central goals of this Core are to widely and effectively communicate information about activities, events, and opportunities—organized across Cores—to relevant audiences and to broadly disseminate the research findings and achievements of LCC members to the research community, NIA, policymakers, and the public. The primary responsibilities of this Core are as follows. (1) This Core develops and maintains the LCC website. The LCC website serves as a centralized platform for sharing information about the Center’s major activities, opportunities, and LCC members’ achievements and research findings. The Aging and Health Launchpad, a new component of the LCC website, will showcase how large-scale data resources that are created and housed at UMN can be used to study topics related to aging and health. (2) Promoting LCC activities and achievements. This Core actively promotes LCC to a broad spectrum of researchers, transcending disciplinary, career stage, and institutional boundaries. This Core also helps LCC researchers reach non-academic audiences, including members of the public and local policymakers. LCC provides opportunities to engage with non-academic audiences; offers training and support to effectively disseminate research findings to non-specialists and non-academics; and compiles bi-annual reports of the accomplishments of LCC and NDIRA members for broad dissemination.